2023 Molecular and Cellular Biology of Lipids Gordon Research Conference and Gordon Research Seminar

2023 Molecular and Cellular Biology of Lipids Gordon Research Conference
Regulation of the Structure and Function of Lipids and Lipid Metabolizing Enzymes in Signaling and
Metabolism
The 2023 Molecular and Cellular Biology of Lipids Gordon Research Conference and Seminar will provide a
platform for scientists from various sub-disciplines of lipid biology, biochemistry, and biophysics to present and
discuss their most recent discoveries that impact the field. The overarching focus is on the “Regulation of the
Structure and Function of Lipids and Lipid Metabolizing Enzymes in Signaling and Metabolism”. This focus
reflects the unique aspects and incredible diversity of lipids and their associated enzymes in regulating
signaling pathways, membrane environments, metabolic pathways, and gene transcription to affect physiology
and pathophysiology. The diversity in both lipid type and distribution plethora is important to the various roles
various lipids they play in these processes. Modulating the levels of various lipids in different organ and
subcellular compartments requires specific regulation of various lipid metabolizing enzymes. These enzymes
are unique in that their substrates are hydrophobic or at least amphipathic. This imposes special requirements
for the regulation and chemistry underlying their function. This conference focuses on understanding how the
structure, chemistry, and dynamic distribution and regulation of these enzymes modulate lipids to affect
signaling and metabolism. Invited speakers will anchor nine plenary sessions, and we will select 14 of the 36
talks from the submitted abstracts to capture the most recent groundbreaking research. Daily poster sessions
will encourage lively discussions and feedback. Overall, this conference is designed to attract a variety of lipid
researchers focused on different areas of lipid research to foster a productive exchange of ideas and
encourage collaborations. Enhancing these exchanges is the ambiance of Waterville Valley set in the White
Mountain National Forest. Traditionally, the outdoor activities here stimulates a number of informal and
productive discussions that serve to accelerate research leading to groundbreaking discoveries. These
discoveries advance our understanding of the impact of lipid biochemistry and biophysics in physiology and
pathophysiology.

Public health relevance
Project Narrative for the 2023 Molecular and Cellular Biology Gordon Research Conference It is now recognized that understanding the proper regulation of lipid metabolism is essential to our ability to maintain health and prevent or treat a variety of diseases. The 2023 Molecular and Cellular Biology of Lipids Gordon Research Conference focuses on understanding how this metabolism is regulated. A particular emphasis is placed on understanding how the molecules controlling lipid metabolism are regulated.